Impact of Lifestyle on Cardiovascular and Metabolic Risk Factors in Trauma Exposed Post-9/11 Veterans

Cardiometabolic disease (e.g., type 2 diabetes or cardiovascular disease) is a leading cause of disability and
mortality in the United States, and especially so among Veterans. Posttraumatic stress disorder (PTSD) – a
salient health concern for many Veterans and their families – is linked to an increased risk of cardiometabolic
disease and premature mortality. The precise mechanisms of this relationship are not fully understood.
However, recent research suggests that a diagnosis of PTSD increases the risk for hypertension, dyslipidemia
and obesity, all of which are known predictors of cardiometabolic disease. A better understanding of what
modifiable factors (e.g., lifestyle) influence the link between PTSD and cardiometabolic health and functioning
will aid in the development of novel rehabilitative nonpharmacological interventions (e.g., exercise) for
cardiometabolic disease and disability in Veterans with PTSD. Physical activity (PA) and diet are promising
examples of modifiable lifestyle factors. For instance, regular PA and a healthy diet strongly reduce the risk for
cardiometabolic disease through numerous pathways, such as reductions in blood pressure, blood lipids,
adiposity, and by promoting blood glucose control. Simply put, 80% of all new cases of type 2 diabetes are
attributed to physical inactivity and poor diet. Low cardiorespiratory fitness (CRF) is also a critical factor in the
risk for disability and mortality due to cardiovascular disease. Despite the clear value and potential impact,
there is little research examining relationships between PA and diet, cardiometabolic health, and functioning in
Veterans with PTSD. This is a critical research gap. Physical inactivity and poor diet increase the risk of
cardiometabolic disease and PTSD likely compounds this risk. Veterans with PTSD often lead sedentary lives
and make unhealthy dietary choices placing them in a perfect storm for developing cardiometabolic disease
and related disability. The purpose of this project is to examine the influence of several modifiable yet
understudied lifestyle factors (i.e., PA and diet quality) on indicators of cardiometabolic health, and functioning
in post-9/11 Veterans. The aims of this project are: Aim 1: To examine PA participation as a mechanism
linking PTSD to cardiometabolic health and functioning in post-9/11 Veterans. I will longitudinally assess
associations between PTSD diagnosis, PA, cardiometabolic health, and functioning over time in 250 TRACTS
participants. H1-1: Total self-report PA will mediate the effects of PTSD on cardiometabolic health and
functioning over time, such that lower PA will increase the detrimental effect of PTSD on cardiometabolic
health and functioning. H1-2: PA intensity will moderate the effect physical activity has on cardiometabolic
health and functioning. Supplemental Aim 1A: To validate the use of a self-report clinical measure of PA
against objective measure obtained via accelerometry. Objective measurement of PA is not often
accessible or feasible for VA providers (e.g., time constraints). It is essential that quick self-report PA
measures accurately reflect the PA of Veterans. I will compare data from a self-report clinical PA measure to
objectively measured PA/sedentary time (i.e., accelerometry), CRF, cardiometabolic health, functioning, and
PTSD symptom severity in 100 post-9/11 Veterans. H1A-1: Self-report and objective measurement of PA will
be significantly correlated. H1A-2: Both self-report and objectively measured PA/sedentary time will be
associated with CRF, cardiometabolic health, functioning, and PTSD symptom severity.
Aim 2: To examine diet quality as a mechanism linking PTSD to cardiometabolic health and functioning
in post-9/11 Veterans. I will longitudinally assess associations between PTSD diagnosis, diet quality,
cardiometabolic health, and functioning over time in 200 TRACTS participants. H2: Self-report dietary intake
will mediate the effects of PTSD on cardiometabolic health and functioning over time, such that a poor diet will
increase the detrimental effect of PTSD on cardiometabolic health and functioning.

Public health relevance
Heart disease and diabetes are leading causes of death and disability in the US, especially among Veterans. Posttraumatic stress disorder (PTSD) is a disabling condition that also affects many Veterans. New research suggests that PTSD further increases the risk of developing heart disease and diabetes. What causes this increased risk is unknown. However, individuals with PTSD are often less physically active and make more unhealthy dietary choices than individuals without PTSD. Maintaining a physically active lifestyle, staying physically fit, and eating a healthy diet may be important for reducing the PTSD related risk for heart disease, diabetes and disability. The proposed research seeks to assess how important these lifestyle factors are for reducing the risk of heart disease, diabetes and disability in Veterans with and without PTSD. A better understanding of these lifestyle factors and cardiometabolic health in Veterans will help to clarify how lifestyle interventions can best be applied to the prevention and treatment of long-term disability in Veterans.